Development of a Novel AAV9 Gene Replacement Therapy for Neurofibromatosis Type 2

PROJECT SUMMARY/ABSTRACT
The severe genetic disorder Neurofibromatosis type 2 (NF2) causes tumor growth throughout the nervous
system due to lack of expression of the tumor suppressor protein Merlin. These tumors cause progressive,
debilitating neurological symptoms, including pain, nerve dysfunction, deafness, paralysis, vision problems,
and balance disruption, leading to a substantially shortened lifespan of approximately 36 years. The
socio-economic burden of this disease and the physical and psychological toll on patients and families remain
devastating since current treatment options (surgery, chemotherapy, and radiation) do not work on the majority
of patients and have severe side effects. There are currently no FDA-approved treatment options available for
NF2 patients. To address this unmet need, Merlin Therapeutics is developing an adeno-associated viral vector
9 (AAV9) gene therapy expressing a healthy copy of the NF2 coding sequencing under the control of a
truncated but functional NF2 promoter sequence. This gene therapy approach is unique because it is designed
to allow the expression of the Merlin protein in all cell types affected by the disease at adequate levels.
Extensive preliminary studies compared multiple promoter constructs and showed that the therapeutic lead
vector is efficacious in delivering the Merlin protein and rescuing tumor characteristics in vitro in patient
Schwann cell lines carrying multiple different NF2 mutations and in primary human vestibular schwannoma
cells isolated from a patient tumor sample. Moreover, intratumoral injections of the treatment successfully
reduced tumor growth in a schwannoma xenograft mouse model in vivo. The objective of the current project is
to validate the existing preliminary data and gather additional information on dose-response and safety, as well
as confirm promoter activity and biodistribution of the lead gene therapy candidate in a in larger animal species
(pigs) more closely related to humans. This study fills gaps in the next steps towards translation of this
therapeutic approach to clinic. Upon completion, our Phase II application will aim to support IND-enabling large
animal safety studies. Our long-term goal is to develop a product that provides an effective and safe treatment
to NF2 patients by treating the underlying disease cause and potentially also a broader cancer patient
population who urgently need better therapeutic options.

Public health relevance
PROJECT NARRATIVE Patients suffering from the progressive, currently incurable genetic disorder Neurofibromatosis type 2 (NF2), which causes tumor growth throughout the nervous system, face a shortened lifespan and a lifetime of devastating neurological symptoms that remain unaddressed by current treatment technologies. Merlin Therapeutics is developing a unique gene therapy allowing NF2 deficient cells to produce a healthy version of the lacking NF2 protein in all cell types affected by the disease, thereby addressing the underlying disease cause. The proposed project will confirm existing preliminary data and establish dose-response, safety, and biodistribution data for our lead gene therapy candidate to bridge the gap to the next steps to a future clinical trial and position this vector as a potential preventive and/or treatment for NF2.